Pathogenesis of Neuroinflammation and Neurocognitive Impairment In HIV-infected Young Adult Cannabis Users

Project Summary
HIV-associated neurocognitive disorders (HAND) and neurocognitive impairment (NCI) remain long-term
complications of HIV infection despite effective antiretroviral therapy (ART). Even in early HIV infection and in
young adults who comprise 37% of new HIV infections, HAND impacts daily functioning and increases
morbidity. This impact of HAND in the young will impact the productivity of the work force worldwide. Currently,
our mechanistic insight into HAND pathogenesis in people living with HIV (PLWH) remains limited, and no
validated biomarkers exist to diagnose and manage NCI. HAND is believed to result from sustained
neuroinflammation. Unfortunately, growing evidence suggests inflammation is modulated by drugs of abuse,
including the drug of choice among young adults with HIV: marijuana. Marijuana's immunomodulatory effects
are largely anti-inflammatory, including suppression of T cell function and monocyte activation, the latter of
which is pivotal to HAND immunopathogenesis. This proposal leverages an existing multi-institutional
infrastructure focused on drugs of abuse in adult and adolescent HIV+ patients. Data from our group has found
that 1) THC treatment reduces monocyte activation; 2) compared to unimpaired, impaired patients have
increased CSF markers of neuronal injury (neurofilament (NFL), and 3) single cell RNA sequencing (scRNA-
seq) of cerebrospinal fluid (CSF) from HIV-infected subjects reveals differentiated myeloid cells expressing
damage-associated microglia (DAM) genes (APOE and TREM2) and other markers of monocyte activation.
This proposal will investigate the role of marijuana in modulating neuroinflammation and HAND and identify
a set of candidate biomarkers with potential to perform in the immunomodulatory context of substance abuse.
An ideal candidate biomarker is one that can perform in the context of HIV driven inflammation and
immunomodulation by drugs of abuse. This proposal will be the first to perform comprehensive, multi-domain
immune and transcriptomic profiling to investigate the effects of marijuana on systemic and neuroinflammation,
and its impact on cognition in young people living with HIV (YLWH). Within four groups (NCI-/MJ-, NCI+/MJ-,
NCI-/MJ+, NCI+/MJ+) we will 1) quantify differences in CNS and peripheral inflammatory biomarkers and
markers of neuronal injury; 2) evaluate the potential anti-inflammatory and neuroprotective impact of marijuana
use; 3) determine the impact of marijuana on the cerebrospinal fluid (CSF) cellular transcriptome via single cell
RNA sequencing (scRNA-seq) to identify inflammatory pathways for future interventions; and 4) using novel
PET/MR techniques, quantify microglial activation and neuroinflammation and synaptic density via radiotracers
(peripheral benzodiazepine receptor (PBR)111 and UCB-J, respectively). Via these objectives, this proposal
will provided needed insight into HAND pathogenesis in the context of drug use. From an increased
understanding of its pathogenesis using novel immunological and neuroimaging, results will ultimately help
identify modulatory pathways of inflammation. Results from this study will add to our understanding of the
interplay between cannabinoids and inflammation both within HIV-infected and uninfected young adults. This
proposal has strong potential to lay the groundwork for studies to test novel therapeutics, such as cannabinoid
receptor ligands, and clinical interventions to reduce HAND morbidity in young adults with HIV.

Public health relevance
Public Health Relevance Young adults are disproportionately affected by HIV and have the highest rates of new infections in the U.S. Contrary to intuition, up to one-third of these young adults suffer from HIV-associated neurocognitive impairment (HAND) that impacts daily functioning and long-term brain function. However, the diagnosis of HAND remains difficult due to a lack of biomarkers to measure ongoing inflammation and an incomplete understanding of its causes. Substance abuse, including high rates of marijuana use among young adults, have untold effects on neurocognition and may modulate levels of inflammation. However, the impact of marijuana on inflammation and cognition is understudied despite increasing use and legalization. This study will combine neuroimaging, neurocognitive testing, and advanced immunology to understand HAND immunopathogenesis and identify novel pathways and measures of inflammation. Results will provide much needed data upon which future clinical trials and clinical practice can better diagnose HAND to develop therapies for this common complication of HIV infection in young adults.